Characterizing a Self-Digesting-Mediated Reversible Drug Tolerance Mechanism in Bacteria

SUMMARY
By integrating our expertise in persister cell biology with advanced current technologies, our overall goals in this
project are to characterize a self-digestion-mediated persistence mechanism in bacteria and to explore the
therapeutic potential of this process. Bacterial persisters are rare phenotypic variants that are temporarily tolerant
to high concentrations of antibiotics. These variants are generally nongrowing cells that are genetically identical
to their antibiotic-susceptible kin. Persister cells facilitate the recurrence of chronic infections and serve as a
reservoir for the emergence of drug resistance mutants. As such, elimination of these cells improves clinical
outcomes for the majority of hospital-treated infections, but effective methods for persister elimination remain
limited. The central hypothesis of this proposal is that self-digestion is a mechanism for persister cell formation
in bacterial species. Therefore, deciphering the essential components of this mechanism can potentially provide
a global treatment approach, as self-digestion is a hallmark of many bacterial species. In our previous studies,
we discovered that persisters are mostly derived from stationary-phase cells with a high redox activity that is
maintained by endogenous protein and RNA degradation (i.e., self-digestion). We further determined that loss
of stationary-phase metabolic activity reduces persister levels by preventing the digestion of endogenous
proteins and RNA, yielding cells with enhanced antibiotic sensitivity. Inspired by these promising results, we
propose the following specific aims to explore our central hypothesis. (Aim 1) We will map the self-digestion-
related mechanisms in our model organism, Escherichia coli, using fluorescence-activated cell sorting, reporter
plasmids, gene deletions, chemical inhibitors, metabolomics technology, and novel assays that we have
developed to quantify persisters, viable but non-culturable cells, and intracellular degradation. We will further
test our hypothesis using a clinically relevant microorganism, Pseudomonas aeruginosa, which is the
predominant cause of morbidity and mortality in cystic fibrosis patients with compromised immune systems. (Aim
2) We will utilize a degradable fluorescent protein to develop a novel screening approach for rapidly identifying
chemical compounds that can eradicate persister cells by perturbing the self-digestion mechanisms in E. coli
and P. aeruginosa. The effects of candidate inhibitors on persister levels will be further tested under in vivo
conditions in a mouse model of high cell density infections. Our study is novel and significant on many levels.
Our approach to address our central hypothesis is conceptually innovative. In addition, mapping of this
comprehensive bacterial pathway from its initial exogenous trigger, through its signal transduction, to the source
of antibiotic tolerance, will enable us to develop affective antipersister therapeutics. Finally, this research
program will have a clinical impact by providing a platform to study persistence in different bacterial species and
by serving as a bridge from laboratory investigations to clinical trials.

Public health relevance
NARRATIVE The rise of antibiotic tolerance is one of the most critical global public health threats of the 21st century. Bacterial persisters, which are reversible drug tolerant cells that have been observed in every bacterial species studied so far, contribute to this problem significantly. The eradication of persister cells could aid in curing recurrent and chronic infections; therefore, the main theme of this proposed study is to therapeutically challenge persister cells by exploring a global, self-digestion-mediated persister formation mechanism in bacterial species.